Ultra-sensitive mass spectrometry-based immunopeptidomics using digital microfluidics.

PROJECT SUMMARY
The identification of Tumor-Specific Antigens (TSAs) is critical for developing effective cancer immunotherapies.
Mass spectrometry-based immunopeptidomics has emerged as a powerful tool for unbiased and systematic
identification of TSAs as physical molecules. However, current immunopeptidomics platforms face challenges in
measuring low-abundance TSAs in a precise, sensitive, and reproducible manner from small needle-tissue
biopsies (<1 mg). Inspired by recent advances in single-cell proteomics, microfluidics technology offers a
promising solution to these limitations by providing improved isolation of immunopeptides with higher sensitivity.
For example, recent advancements in microchip pillar arrays have reported a two-fold increase in the yield of
detected immunopeptides, clearly demonstrating the benefit of microfluidics in immunopeptidomics. However,
state-of-the-art microfluidics methods in immunopeptidomics rely on complex tubing networks, pump systems,
and demanding antibody requirements. These complexities present significant barriers to the widespread
adoption of this technology within the cancer research community. Alternatively, digital microfluidics is
fundamentally different and enables precise manipulation of micro- or nano-droplets using an electrode array
and the principle of electrowetting on dielectric. Key advantages of digital microfluidics are the ability to control
individual micro/nano-droplets of liquid without the need for micropipettes, pumps or complex tubing networks.
To date, digital microfluidics has been widely used in biomedical research and has demonstrated success in
various applications, but its potential for immunopeptide profiling and TSA discovery remains untapped. The
overall objective is to enhance the efficiency of immunopeptide isolation from small cell populations by leveraging
digital microfluidics. We hypothesize that miniaturization and automation of the immunopeptide isolation
procedure by digital microfluidics will enable TSA discovery from as few as 10,000 to 100,000 tumor cells using
a timsTOF Ultra mass spectrometer. Such advancement will lay the cornerstone for pioneering single-cell
immunopeptidomics. In Aim 1, we will create the first “all-in-one” digital chip for ultra-efficient and scalable
isolation of immunopeptides for TSA discovery at unprecedented sensitivity. The method will be rapid and
unbiased by applying and integrating relevant surfactant, immunopeptide elution process, clean-up on the digital
platform, and a direct interface with the liquid chromatography system. Importantly, our digital approach will be
antibody-free, thereby drastically enhancing its scalability for wide adoption by the community. We will apply the
“all-in-one” digital chip on low numbers of lung tumor cells isolated from patients to identify actionable TSAs. The
project will establish a highly innovative measurement capability for personalized cancer immunotherapy.

Public health relevance
PROJECT NARRATIVE We are developing a new method to find specific targets in cancer cells that can help the immune system fight tumors better. By using tiny channels and special beads, we aim to identify these targets quickly and accurately from small amounts of tumor tissue. This could lead to more effective personalized treatments for cancer patients in the future.